Novel compounds that inhibit transactivation of N-terminal domain of the androgen

DESCRIPTION (provided by applicant): Treatment for advanced prostate cancer involves the reduction of the patients' levels of testosterone (androgen). Unfortunately, this form of therapy is not curative and eventually the disease will return in a castrate resistant form (also called hormone refractory or androgen-independent). Once the disease is castrate resistant, the survival time is approximately two years before the patient will succumb to his disease. There are not any effective therapies currently available for these patients. To develop new therapies, a target must be known. Our laboratory has identified the N-terminal domain of the androgen receptor as a novel therapeutic target for drug development. This target is supported by data showing that the N-terminal domain of the androgen receptor is activated by alternative pathways in the absence of androgens and targeting this domain of the receptor blocks tumor growth and progression in vivo. We have identified two structurally unrelated small molecules (EPI-001 and SINT1) isolated from marine sponges that inhibit transactivation of N-terminal domain of the androgen receptor. These small molecules have in vitro (cell culture) and in vivo (animal) specific activity to block proliferation and androgen receptor activity, and decrease tumor burden of castrate-resistant xenografts. Our ultimate goal is to move these compounds, or their structural derivatives, into clinical trials. To meet this goal a number of items need to be fulfilled and several are addressed here. Specific Aim 1 will synthesize and test single stereoisomers or achiral derivatives of EPI-001 in cell based assays for activity and make a synthetic, and more stable derivative of SINT1. Specific Aim 2 will delineate the molecular mechanisms involved in EPI-001 and SINT1 inhibition of transactivation of the AR NTD. Specific Aim 3 will test the efficacy of SINT1 and EPI-001 and various analogues in different models of prostate cancer. While conventional therapy has concentrated on androgen-dependent activation of the androgen receptor through its C-terminal ligand-binding domain, our concept of blocking transactivation of the N-terminal domain of the androgen receptor for the therapy of advanced prostate cancer has not been previously addressed. There are no inhibitors to the N-terminal domain of the androgen receptor and such compounds would represent a new class of antagonists. The capability to inhibit transcriptional activity of the androgen receptor by targeting the N-terminal domain to block tumor growth in the absence of testicular androgen presents a new direction for the development of antagonists to the androgen receptor for the clinical management of prostate cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Once prostate cancer becomes castrate-recurrent there are no effective therapies that can be offered and the patient will succumb to his disease in approximately two years. There is mounting evidence supporting the concept that development of castrate-recurrent disease is causally related to molecular changes affecting the function of the androgen receptor. Here we propose to develop small molecules that target a unique region of the androgen receptor that will delay or prevent hormonal progression to the terminal stage of prostate cancer. Project Narrative Once prostate cancer becomes castrate-recurrent there are no effective therapies that can be offered and the patient will succumb to his disease in approximately two years. There is mounting evidence supporting the concept that development of castrate-recurrent disease is causally related to molecular changes affecting the function of the androgen receptor. Here we propose to develop small molecules that target a unique region of the androgen receptor that will delay or prevent hormonal progression to the terminal stage of prostate cancer. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Presently, there are no effective therapies for the treatment of patients with castrate resistant prostate cancer (CRPC, also called hormone refractory or androgen independent). Once the disease becomes castrate resistant, the average survival time is two years. One mechanism suggested to play a role in CRPC is activation of the androgen receptor (AR) in the absence of testicular androgens. Expression of many of the same genes that are increased by androgens become re-expressed in CRPC xenografts. This suggests transactivation of the AR in spite of reduced levels of androgen which is consistent with nuclear localization of AR protein in secondary prostate cancer tumors. Other data supporting the role of AR in CRCP include amplification of the AR gene, delayed onset of CRPC by altering the timing and sequence of use of antiandrogens targeting the ligand-binding domain (LBD), the necessity of AR for the proliferation and tumor growth of castration-recurrent prostate cancer cells, and the fact that the AR can be activated in the absence of androgen (and serum) by alternative signaling pathways involving its N-terminal domain (NTD). The AR NTD contains the activation function-1 (AF-1) region that contributes most, if not all, of the transcriptional activity to the AR, rather than AF-2 in the C-terminal ligand-binding domain (LBD), making the AR unique from other steroid receptors. The AR NTD is intrinsically disordered and thought to require protein-protein interactions for induced folding to acquire transcriptional activity. Currently there are no drugs that target the AR NTD which would potentially block the activity of the AR regardless of ligand. To address this need, we identified two structurally unrelated small molecules, called EPI-001 and SINT1 that inhibit transactivation of the AR NTD. Objective/Hypothesis: This proposal is based upon the hypothesis that activation of the AR plays a role in CRPC and is mediated by transactivation of the NTD. We have identified 2 novel small molecules that specifically inhibit transactivation of the AR NTD without altering the activities of related steroid receptors. Consistent with the specificity observed, these compounds caused cytoreduction of CRPC in castrated mice without causing general toxicity to the animal. Our ultimate goal is to achieve Investigation New Drug (IND) status for both compounds for approval of progressing to clinical trials. Specific Aim 1 will synthesize and identify the active stereoisomer of EPI-001 and synthesize a less labile derivative of SINT1. Cell based assays will be applied to test activities of the single stereoisomers of EPI-001 and synthetic SINT1 derivatives. These assays will include: transactivation of the AR NTD; IC50s for each compound; steroid receptor specificity; and proliferation/cytotoxicity assays. Specific Aim 2 will determine the molecular mechanisms of EPI-001 and SINT1. These studies will include: identification of proteins that interact with biotinylated derivatives; changes in induced folding of AR NTD; alteration of ligand-binding; changes in N- terminal with C-terminal interaction and protein-protein interactions; global changes in gene expression and AR:ARE interaction; and inhibition of kinases. Specific Aim 3 will test the compounds using xenografts of LNCaP, 22Rv1, PC3, and importantly patient CaP tissue of differing androgen sensitivities. Impact: There is a crucial need to develop therapies for the treatment and prevention of CRPC. Activation of the AR by targeting its NTD is a possible mechanism involved in CRPC. Using this knowledge we have identified lead compounds for developing new drugs that can be used to delay or cure CRPC. While conventional therapy has concentrated on androgen-dependent activation of the AR through its C-terminal LBD, our concept of blocking transactivation of the NTD for therapy of CRPC has not been previously addressed. This work has potential broad application to other steroid hormone and orphan receptors serving as a paradigm to develop therapeutics to intrinsically disordered regions of these transcription factors. These unique drug development experiments involve a multidisciplinary team that includes expertise in: AR NTD and prostate cancer (Dr. Sadar); medicinal/natural compounds chemistry (Dr. Andersen); and animal models (Dr. YZ Wang).